AUTOANTIBODIES TO LENS CRYSTALLINS

There are reports that one of the causes of age-related cataract is an autoantibody reaction to the lens. The autoantibodies reported to cause this response do not appear to be present in the samples that we have examined. We have found that there is one protein that is immunoreactive in all the sera tested. This protein was mapped by two-dimensional gel electrophoresis. The spot maps to the area of the gel generally occupied by the gamma-crystallin family. This protein was cut from the gel and is being sequenced.